The impact of diet patterns and PUFA-related polymorphisms on ulcerative colitis in Hispanics

Summary
This is an extension of my K23 study for a period of 12 months to complete recruitment for the study, perform
pilot metabolite and microbiota analyses, and acquire necessary training in ‘omic’ data analysis and interpretation
important for my career development and R01 proposal. My K23 research project delves into the study of
ulcerative colitis (UC), a devastating immune-mediated disease that is on the rise globally including among
Hispanics. The proposal was based on the hypothesis that greater adoption of a Western diet among Hispanics
in the US could explain differences in UC severity observed in my prior studies between US and foreign-born
Hispanics. A Western diet, high in n-6 to n-3 polyunsaturated fatty acids (PUFA), is up to 10-20 times the
recommended intake and is considered pro-inflammatory. However, heterogeneity of results in dietary
intervention studies suggests that underlying genetic variation in PUFA metabolism may modify diet effects. Our
preliminary data for the K23 indicated that Hispanics with UC have polymorphisms in PUFA not present in
Hispanic controls. I hypothesized that Hispanics with UC whose diet follows a higher Western dietary pattern,
defined by a reproducible dietary pattern score, would have more active disease, than those whose diet scores
are lower. Further, I proposed that carriage of PUFA variants augments the effect of a Western diet on relapse
leading to a disproportionate pro-inflammatory effect of the diet. I am examining the influence of a Western
dietary pattern on relapse of UC among Hispanics (Aim 1). We are testing PUFA variants and whether carriage
of these enhances the effect of a Western diet on UC relapse (Aim 2). A total of 320 self-identified, Hispanic
participants with UC were recruited and we will include these for our diet portion in Aim 1. We have included a
total of ~700 Hispanics with UC and ~900 Hispanic controls for our Aim 2 genetics portion. We have recruited a
total of 320 patients already for Aim 1 and have identified that Western diet patterns are associated with relapse
in a subset of 214 analyzed. We have detailed demographic and clinical information on these patients, as well
as whole genome sequencing of PUFA variants pending to be analyzed upon completion of recruitment.
Participants complete a validated food-frequency dietary questionnaire, at baseline and at 1-year follow up.
Disease activity using the validated simple clinical colitis activity index will be assessed at baseline and at 1 year
follow up in combination with fecal calprotectin. We have calculated scores for a Western dietary pattern and are
determining the influence of diet on relapse using multivariable regression analysis. In Aim 2, we will examine
the effect of PUFA variants on relapse and determine gene-environment interactions influencing disease activity
between PUFA variants and Western diet upon completion of recruitment. During the extension period, I will
complete data visits for all 320 patients to complete Aims 1 and 2 and work on analyzing the stool microbiome
species, function and derived metabolites and their associations to disease relapse in a subset of 24 patients
with complete diet and clinical data. Results gathered from this study will be a step towards personalizing IBD
treatment by targeting specific dietary patterns in Hispanics with highest metabolic genetic risk.

Public health relevance
Project Narrative This is an extension of a prospective study that examines dietary and genetic underpinnings of Hispanics with ulcerative colitis (UC) and determines risk for relapse over the course of 1 year. At the end of the study extension, we seek to gain a better understanding of the role of a Western diet on UC relapse when underlying genetic susceptibility for abnormal polyunsaturated fatty acid (PUFA) metabolism exists. During the extension I will also explore associations between the stool microbiome function and derived metabolites and disease relapse. The findings from this study may guide food-based recommendations based on individual genetic and baseline microbiome variation in future studies.